Translational Research in Pelvic Floor Disorders

DESCRIPTION (provided by applicant): My long-term career goal is to substantially improve women's health in the field of urogynecology by becoming a well-trained, independent clinician-scientist who is able to use innovative tools to identify the root causes of pelvic floor disorders and translate those findings into improved clinical practice. To achieve this goal, I have obtained the essential clinical and surgical training in urogynecology to fully comprehend the challenges in prevention, management and treatment of pelvic floor disorders. I have also developed a robust foundation in clinical research and modeling through my MPH in epidemiology and prior research endeavors. Through these collective experiences, I ultimately realized that advances in translational research, focused on the pathophysiology of pelvic floor disorders, are needed to revolutionize women's health in urogynecology. Thus, I am applying for this K23 Mentored Patient-Oriented Research Career Development Award in order to obtain advanced training and mentorship in human genetics and genetic epidemiology. Topic: Female pelvic floor disorders (PFD) represent a major public health burden given their high prevalence, impairment of quality of life, and substantial economic costs. The underlying pathophysiology of these disorders is not well understood, and without this critical knowledge, effective preventive strategies and long-term treatments have not been developed. Identification of the fundamental causes of PFDs will be achieved through innovative translational research. Plan: My multidisciplinary educational plan entails acquiring additional skills in genetic epidemiology through intensive coursework, dedicated mentoring and productive research. My research will focus on identifying genetic risk factors for pelvic organ prolapse through a candidate gene association study (Aim 1). Through this research, I will gain crucial hands-on experience and knowledge, strengthen collaborations within and across institutions, and establish the groundwork for future, large-scale investigations. With advances in our understanding of the genetic susceptibility for prolapse, it is critical to simultaneously explore how we will eventually integrate these genetic findings into clinical practice. Thus, I will also estimate the potential clinical and economic impact of a genetic susceptibility test for prolapse using a computer simulation model (Aim 2). This novel proposal will foster valuable collaboration between clinical scientists and geneticists and advance the implementation of translational medicine into the evolving field of urogynecology in order to ultimately improve women's health. PUBLIC HEALTH RELEVANCE: Female pelvic floor disorders represent a major public health burden given their high prevalence, impairment of quality of life, and substantial economic costs. Identifying the fundamental causes of pelvic floor disorders and translating these findings into improved preventive and treatment strategies will significantly impact women's health.

Public health relevance
PROJECT NARRATIVE Female pelvic floor disorders represent a major public health burden given their high prevalence, impairment of quality of life, and substantial economic costs. Identifying the fundamental causes of pelvic floor disorders and translating these findings into improved preventive and treatment strategies will significantly impact women's health.